Bioengineered lymphatic regenerating platform for treatment of breast cancer related lymphedema

Project Summary
Breast cancer remains a global affliction with more than 1.5 million people impacted each year worldwide and is expected
to increase in incidence. Breast cancer related lymphedema (BCRL) is a common and feared result of breast cancer, with
40% of breast cancer survivors being tethered to the lifelong condition. Despite decades of research, there is no cure for
BCRL, and the current standard of care remains life-long symptom management with compression devices that lead to
infections, tissue damage, and increased hospitalizations. Recent advancements in microsurgery offer hope for improved
lymphatic drainage. However, these procedures have their limitations such as mismatches in replacement vessel size,
requiring two invasive surgeries that may lead to secondary lymphedema, and fibrosis. Tissue-engineered alternatives
have yet to successfully resolve lymphedema and regenerate lymphatics on their own and often result in foreign body
response, leading to graft morbidity.
To address these key obstacles, we propose a unique alginate mechacrylate (AlMA) hydrogel platform that is
coated with an anti-fibrotic small molecule and contains programmable cell therapies for lymphatic vessel recruitment and
regeneration to correct lymphedema. We have demonstrated that AlMA hydrogels can encourage lymphatic vessel
guidance within a pre-clinical lymphedema model. Additionally, a synthesized small molecule will be modified to AlMA that
avoids foreign body response (FBR) from the host immune system that would normally lead to graft fibrosis and therefore
maintains viability of loaded cell therapies. PI Veiseh has shown that such immunoprotective modified hydrogels limits
FBR in rodent and primate models. Additionally, PI Veiseh has established a method to engineer non-tumorigenic and
human-sourced cells to produce a local and targeted therapy that have advanced to clinical applications. Here, we have
engineered cells to regulate vascular endothelial growth factor-c (VEGF-C) secretion and termination. VEGF-C is a factor
responsible for regeneration of lymphatic vessels, that will be encapsulated within our guiding hydrogel. PI Zhang and
Chang have experience in tissue engineered solutions for lymphedema clnicalal applications, along with pre-clinical
lymphedema models to evaluate lymphatic regeneration, reduced swelling, and safety. PI Dondossola has demonstrated
real-time foreign body response to implanted biomaterials utilizing intravital microscopy, such technique will be applied to
investigate the mechanism behind foreign body response to our platform along with lymphatic regeneration.
In this research project, we will fabricate 3D hydrogels and optimize VEGFC engineered cell dosage to elevate
pro-lymphangiogenesis features such as vessel guidance and regeneration in vivo. The AlMA hydrogel will be modified to
resist FBR in rodent models and will be fabricated and combined with optimized lymphangiogenic cells to encourage local
regeneration. Upon regeneration of the hydrogel graft in vivo, the graft will be evaluated for reinstatement of flow and
reduction of swelling within rodent and porcine hindlimb lymphedema models. Intravital imaging will provide insights on
the fibrosis and regeneration process in real-time. We anticipate that upon completion of this project, we will have
identified a therapeutic AlMA hydrogel that succeeds in pre-clinical rodent lymphedema models for clinical translation.

Public health relevance
Project Narrative Breast cancer affects over 2.26 million women worldwide; and, despite an 80-90% survival rate, about 40% suffer from breast cancer-related lymphedema (BCRL). Currently, treatments only manage symptoms, not the underlying issue. Here, we propose a novel alginate-based hydrogel and an engineered pro-lymphangiogenic cell platform that is biocompatible, biodegradable, protects against graft rejection, and promotes lymphatic vessel regeneration and guidance to resolve lymphedema.